Antimicrobial Biomaterials that Interfere with Bacterial Nucleotide Messenger Signaling

PROJECT SUMMARY/ABSTRACT
Medical device-associated microbial infection arises from pathogenic bacterial adhesion and subsequent
biofilm formation on devices. It is known that bacterial intracellular nucleotide second messenger signaling
plays an important role in biofilm development. Interference with these nucleotides signaling could provide a
novel approach to address the problem of pathogenic biofilm formation on biomaterial surfaces. This
application proposes to synthesize small molecule derivates of 4-arylazo-3,5-diamino-1H-pyrazole (named as
SP02, SP03, and SP04) and tether them to polyurethane (PU) and polydimethylsiloxane (PDMS) biomaterial
surfaces so that the small molecules can interfere with nucleotide signaling and interrupt biofilm formation in a
way that will both reduce the formation of biofilms and increase the antibiotic efficacy for treating biofilms that
do develop. Through testing 4 clinically relevant pathogenic biofilm bacteria on modified surfaces in vitro and in
vivo, a new approach for creation of improved antimicrobial biomaterials for implantable medical devices such
as catheters will be developed. The central hypothesis is that “biomaterial surfaces tethered with small
molecule derivates of 4-arylazo-3,5-diamino-1H-pyrazole can inhibit and interrupt biofilm formation and growth
by interfering with intracellular nucleotide signaling. This leads to disruption of biofilm formation and increases
efficacy of antibiotics, therefore making microbial infection treatable using standard antibiotic therapy.” To test
this hypothesis, four specific aims are proposed. Aims 1 and 2 will focus on in vitro assessment of the
effectiveness of three small molecules and these small molecules bonded PU and PDMS biomaterial surfaces
for inhibiting biofilm formation and increasing antibiotic efficacies, as well as addressing biocompatibility. The
nucleotide levels and RNAseq will be quantified to determine the effects of small molecules on bacterial
intracellular nucleotide signaling. Through these experiments, the molecule tethering approach that leads to
the greatest inhibition of biofilm formation will be identified for in vivo studies. Aim 3 will test the antibacterial
properties and tissue response to small molecule modified biomaterials using a 7-day subcutaneous infection
rat model to validate the findings of small molecule functionalized polymers identified from Aims 1 and 2. To
accelerate the application of new approach in medical devices, commercial pediatric central venous catheters
will be modified with small molecules. Biofilm formation and antibiotic efficacies will be tested using a total
implantable venous access port (TIVAP) in vitro and in vivo in Aim 4. The success of experiments described
will allow progression to in vivo studies of other medical devices and large animal studies for preclinical trials,
as well as providing important basic science information on nucleotide messenger signaling in biofilm formation
and control.

Public health relevance
Project Narrative Bacterial intracellular nucleotide second messenger signaling plays an important role in biofilm development. The project proposes to develop small molecules and tether these molecules on polymeric biomaterial surfaces so that small molecules can interfere with nucleotide signaling pathways and interrupt biofilm formation and growth on biomaterial surfaces, and will increase the efficacy of antibiotics against biofilm bacteria in vitro and in vivo.